Administrative Core

SUMMARY/ABSTRACT
The purpose of the Administrative Core (AC) is to provide and integrate scientific leadership, administrative
support, and fiscal management, for the entire Program Project. The three primary functions of the
Administrative Core (AC) include:
1. Project management including communications logistics, fiscal oversight, compliance monitoring, and
submission of progress reports to NIH
2. Scientific planning, coordination and evaluation which will involve regular meetings of project and
core leaders to develop common definitions and measures to be applied across studies, shared
systems for recruiting subjects, tracking policies and new and modified products, supporting pilot
studies as appropriate to advance study aims, and soliciting and responding to feedback from an expert
external advisory committee; and
3. Facilitating the dissemination of research products by: 1) publishing, presenting and tracking
research products produced by the P01; 2) creating dissemination products showcasing the findings
from the P01; 3) partnering with key stakeholder organizations, and 4) maintaining the P01 website
were study protocols, research products and policy tracking is shared.
The AC will be located at the Medical University of South Carolina (MUSC). The Director of the AC will be K.
Michael Cummings, PhD, MPH who will also serve as MPI (along with Dr. Geoffrey Fong and Andrew Hyland)
of the overall Program Project. Dr. Cummings will be responsible for overall project management of the P01.
Dr. Hyland will be responsible for coordinating P01 internal and external scientific planning and evaluation. Dr.
Fong will lead dissemination activities of this P01. Dr. Cummings has previously served as the PI and AC
Director of the AC for the current P01 and has decades of experience leading multi-institutional NIH grants
(P50 CA111236, 2004-2009 and P01 CA138389, 2009-2015), thus he is very experienced in the operations of
the ITC Project and organization and oversight of AC services. Cynthia Smalls will serve as the Program
Manager for the P01. She previously served as the Program Manager for MUSC's current P01 and its related
supplements and therefore is experienced in the operations of a P01.

Public health relevance
NARRATIVE The purpose of the Administrative Core (AC) is to provide and integrate scientific leadership, administrative support, and fiscal management, for the entire Program Project. The three primary functions of the AC include: 1) project management; 2) scientific planning, coordination of activities across projects, and evaluation; and 3) dissemination of research findings.